Understanding PDI-related neurotoxicity and advancing preventative approaches

? DESCRIPTION (provided by applicant): Protein disulfide isomerase (PDI) is an endoplasmic reticulum (ER)-resident oxidoreductase chaperone that catalyzes the maturation of disulfide-bond-containing proteins. S-nitrosylated PDI (SNO-PDI), which is the chemical modification of its catalytic cysteine in response to nitrosative stress, has been found in post-mortem brains of Parkinson's and Alzheimer's disease victims along with synphilin-1:alpha-synuclein protein aggregates (called Lewy Bodies). Additional studies in cells revealed that levels of SNO-PDI formation directly co-related with the aggregation and accumulation of the minor but critical Parkinsonian biomarker synphilin-1 in a NO-sensitive manner. While SNO-PDI formation leads to the accumulation of polyubiquitinated proteins, expression of native PDI (non-SNO-PDI) attenuates these effects in a Parkinsonian cell model. These data show that PDI is neuroprotective and underscore the need for functional preservation of PDI's catalytic activity as a key preventative approach to pathogenesis of nitrosative-stress-related Parkinson's. The data also suggest the involvement of PDI dysfunction in the pathogenesis of neuropathies such as the Lewy Body Variant of Alzheimer's (LBVAD) and Alzheimer's. However, there is still a gap in studies designed to determine whether other neurotoxicity-related biomarkers accumulate as a function of SNO-PDI formation. We hypothesize that SNO-PDI formation may provoke aggregation of alpha-synuclein, the major Parkinsonian and LBVAD biomarker protein and Lewy-body constituent. As a corollary to our hypothesis, it is possible that strategies designed to prevent SNO-PDI formation are neuroprotective and prophylactic to Parkinson's. The hypothesis will be tested by examining the aggregation of alpha-synuclein as a function of nitrosative insult in a cell line model. Furthermore, the translational feasibility of ellagic acid, Na-betahydroxybutyrate and Ferrostatin-1 analogs, which our lab has preliminarily demonstrated as being neuroprotective, will be assayed in a rotenone rat Parkinson model. The overall objective of this project it to lay the foundation for long-term work involving the development of pharmacologically relevant small molecule therapies that are neuroprotective by mitigating the effects of oxidative and nitrosative stress.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed work examines the association of elevated levels of nitric oxide and the resulting failure of a key chaperone involved in protein folding wit the onset of Parkinson's disease. The proposal also seeks to advance mechanisms designed to protect chaperone function through diet-derived and other select small molecules, with the goal of preventing Parkinson's disease.